Michigan's VNRFRPS Cooperative Agreement for a Learning Management System Develop

The referenced funding opportunity announcement focuses on efforts to advance the nationally integrated food safety system by assisting retail food regulatory programs to achieve conformance with the Voluntary National Retail Food Regulatory Program Standards by developing, implementing, and improving the infrastructure necessary to support conformance with the VNRFRPS. The Michigan Department of Agriculture and Rural Development's (MDARD) experience as an enrollee in the VNRFRPS gives us a clear understanding of how the standards focus your food safety program on the reduction of risk factors and the issues surrounding the implementation of an active managerial control program within the retail food sector. MDARD's proposal would support the development of that infrastructure by developing and implementing a Learning Management System (LMS). It would offer a tool for agencies to use in meeting the requirements outlined in the VNRFRPS specifically Standard 2, Training. This is MDARD's first plan to resolve this issue and MDARD's proposal builds upon our current work with our 45 LHDs during the accreditation and standardization processes. During these processes both MDARD and the LHD have identified that the lack of an effective LMS for tracking and documenting an individual's training as a problem. This creates an issue for MDARD and LHD in assuring that all staff who are delivering food safety inspections are fully trained and maintaining their continuing education requirements as needed. In order for a LHD to meet the requirements of the VNRFRPs they must be able to demonstrate that they have a fully trained inspection staff current on their training requirements and that any new staff hired also meet the requirements for training. Even small agencies staffed with two or fewer inspectors have experienced difficulties, resulting in reluctance to enroll in VNRFRPS. MDARD will develop the LMS through a consensus process with our LHD and other partners. MDARD's long track record of consensus building with the LHD and other state and federal agencies will help us to develop requirements, implement, and train staff to use a LMS system. A comprehensive LMS would enable any food safety agency to successfully document training and remove a roadblock for enrollment in the VNRFRPS, resulting in the delivery of a complete food safety program to their constituents. MDARD and LHD successful implementation of a LMS can be used as a model for a variety of food safety agencies at various governmental levels; local, regional, tribal, and state. MDARD believes that the use of a LMS will become a best practice and we will support this concept and project nationally. Michigan has been an active member of a variety of partnerships, initiatives and associations on the local, state, regional and national level. Michigan's participation and continued work with those organizations will help to ensure that this project will align with and support the goal of a fully integrated food safety system.

Public health relevance
Project Narrative Michigan Department of Agriculture and Rural Development (MDARD) The referenced funding opportunity announcement focuses on efforts to advance the nationally integrated food safety system by assisting retail food regulatory programs to achieve conformance with the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) by developing, implementing, and improving the infrastructure necessary to support conformance with the VNRFRPS. The proposal would support the development of that infrastructure by developing, and implementation of a Learning Management System (LMS) for use in multiple jurisdictions across the nation, as it would offer a tool for food regulatory programs to use in meeting the requirements outlined in the VNRFRPS specifically standard 2, Training. A comprehensive LMS would enable any food safety agency to successfully document training and remove a roadblock for enrollment in the VNRFRPS and the delivery of a complete food safety program to their constituents. __SpecificAimsTextDelimiter__ Research Strategy RFA-FD-12-011 Advancing the Conformance with the Voluntary National Retail Food Regulatory Program Standards (VNFRPS) (U18) Michigan's VNRFRPS Cooperative Agreement for a Learning Management System Development and Implementation Project Project Aims: Developing and implementing an electronic Learning Management System at both a state and local level to facilitate compliance with the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS). Further integration of the Michigan's Food Service Sanitation Food Safety Minimum Program Requirements and the VNRFRPS, primarily Standard #2, Training, and other standards related to inspection, auditing, standardization and enforcement. Strategy: Implement a robust flexible LMS that supports both MDARD and LHD's needs for documentation, tracking and reporting of training. System attributes include the following: reporting on the availability of training, tracking of in process training and training completed, by staff. The development process for the requirements gathering and implementation training plan for the LMS would be completed through a consensus process. Identify as a requirement the ability of the LMS to generate reports that support both compliance with the VNRFRPS and agencies training needs. Develop an implementation plan which will be used to train MDARD and LHD staff on how to implement, use and manage the LMS as their training documentation system. Pilot the proposed implementation plan with MDARD staff and select LHD to help assure that all partners understand and can support the process, procedures and implementation plan for an electronic LMS. Review and adapt implementation plan after piloting with LHD and MDARD staff to further refine and improve on the plan prior to rolling out to the remainder of the LHD and MDARD divisions and/or sections. To further integrate the MPR training requirements so that they are more equivalent to the training requirements outlined in Standard 2 of the VNRFRPS. Identify changes to the MPRs using the MPR review and consensus process in order to bring the two standards into alignment. Propose changes to the MPR review board for inclusion in cycle 6 of the MPRs. Summary: The above approach is designed to result in measurable improvement in the capability of Michigan local, state food regulatory agencies to protect public health, by assuring all of our partners that the work completed by state or local is consistent and satisfactory in approach and action. By actively engaging our LHDs in this project, MDARD believes that this is an important step in building a nationally integrated food safety system. LHDs in Michigan have regulatory authority over the large and diverse food service segment of our food supply. LHDs also employ the majority of non-federal food regulatory officials in this state. Better alignment of plans, procedures and training across local, tribal and state levels will result in the wider application of risk factor interventions, and the incorporation of active managerial controls throughout the retail food industry. Thus assuring uniformity between regulatory agencies and assuring industry and consumers that food protection programs whether delivered by a federal, state, tribal or local food safety agency is focused appropriately on the protection of the nation's food supply.